Unraveling heterogeneity in endometrial cancer via integrated single cell genotype-phenotype mapping

SUMMARY
Endometrial carcinoma is a common but comprises a highly heterogeneous group of cancers, including subsets
with hypermutation secondary to microsatellite instability or POLE mutation, and others with TP53-driven
genomic instability. Defining molecular subtypes has led to improved prognostication and prediction of response
to therapies. However, there remains a critical need to further refine classification, prognostication, and develop
personalized treatment approaches. Current subtyping is based on bulk DNA profiling, which limits inferences of
genetic subclones and phenotypic heterogeneity that emerge within individual cells. Further, comprehensive
single cell genomics studies on endometrial cancer are sparse despite its increasing incidence worldwide.
Here, we will develop and deploy novel single-cell technologies in all molecular subgroups of endometrial
carcinoma. Though single cell technologies, including spatial platforms, are becoming more accessible, most
technologies rely on access to fresh tissue samples for data generation. We propose to overcome these
limitations via Genotyping In Fixed Transcriptomes (GIFT). GIFT uniquely combines genotyping mutations and
profiling transcriptomes in the same single cells with full compatibility with FFPE tissue. This approach enables
study of large, comprehensively characterized retrospective cohorts of endometrial carcinoma to resolve
genotypic and phenotypic heterogeneity and relate genomic correlates to these rich phenotypic annotations,
including tumor clonality patterns, evolution, and response to therapy.
In Aim 1, we develop bioinformatics tools necessary to implement mutation (genotype) calling at the single cell
and metacell levels, integrating these data with single cell transcriptomes to define subclones and construct
lineage relationships. In Aim 2, we apply these computational tools in GIFT-profiling of existing cohorts of >600
endometrial carcinomas to map clonal trajectories at single timepoints and in longitudinal samples across many
timepoints, thus delineating both static and dynamic features of heterogeneity, clonal states, and trajectories in
endometrial cancer. In Aim 3, we resolve single cell spatial organization of endometrial cancer across genotypic
subclones, transcriptional states, and surrounding microenvironment. Together, our work will provide a
comprehensive profiling of endometrial carcinoma by refining the complex nature of endometrial cancer
heterogeneity, clonal organization, and tumor evolution. We anticipate our results will directly inform the
identification of biomarkers of treatment response and recurrence in endometrial carcinoma.

Public health relevance
Project Narrative Endometrial cancer is the most common cancer in the female genital tract but is understudied, particularly at the single cell level. We aim to leverage our unique biobank of endometrial cancers with detailed clinical annotations to resolve tumor heterogeneity and clonal evolution at the genetic and transcriptomic level via novel and innovative technologies. Our findings may unveil molecular associations of tumor recurrence and response to specific therapies—an approach that may be broadly applicable to tumors beyond the endometrium.